HD2A Research Adoption Support Center (RASC)

OVERALL: PROJECT SUMMARY/ABSTRACT
In response to the National Institutes of Health RFA-DA-22-050, we herein propose a HEAL Data2Action
Research Adoption Support Center (RASC). The main purpose of the RASC is to stem the tide of overdose
death in the US by leading a scientifically-driven support endeavor designed to effectively translate evidence-
based interventions for substance use disorders and pain. Presently, overdose death escalates. Dissemination
and implementation (D&I) science is the methodological bridge to both the scientific and public health gaps.
Yet D&I science is understudied and underutilized in response to the opioid epidemic. Emblematic of
heightened awareness for D&I scientific potential, the HEAL D2A Program will be launched. The program
features 10-12 Innovation Projects, and, in addition to the RASC, two additional centers: Modeling and
Economic Resource Center and Data Infrastructure Support Center. The RASC will optimize and elevate the
D&I capability of the overall HD2A program. In this OVERALL component, we document how the RASC is
organized into four synergistic and dynamic cores: Administrative, Substance Use Implementation Support
Core, Pain Implementation Support Core, and a Research & Evaluation Core. Three overarching specific aims
are strategically ordered across the RASC and all its cores follows: To ASSESS the current state of the HD2A
Innovation Projects on D&I research capability, and develop an empirically-based catalog of evidence-based
and emerging interventions for substance use disorders and pain; to ASSIST on how Innovation Projects can
improve D&I methods and measures through on demand technical assistance and the use of an innovative
Implementation Support Plan, and to develop SUD and Pain Intervention D&I Resource Guides; and lastly, to
ADVANCE the HD2A Innovation Projects toward greater potential for scalability and sustainment. The RASC is
led by 4 MPIs with demonstrated track records of D&I research and practice in the fields of substance use and
pain interventions: McGovern (Stanford), S. Becker (Brown), W. Becker (Yale) and Brown (Northwestern). The
MPIs are joined by complementary expert core co-directors, and have assembled an unmatched roster of
highly-qualified leaders in these fields—carefully selected, organized and ready to provide the necessary
implementation support across the HD2A program. This RASC meets all the specified requirements as
outlined in the RFA. What distinguishes this RASC is our bold ambition to enhance not only the D&I capability
of the HEAL HD2A program, but to influence the field far beyond the confines of the HD2A initiative. We intend
to elevate the D&I paradigm of substance use and pain intervention research, and thereby ensure ubiquitous
and equitable access to proven interventions by the people and communities who need them the most.

Public health relevance
OVERALL: PROJECT NARRATIVE The HD2A Research Adoption Support Center (RASC) assembles a uniquely qualified team with expertise in dissemination and implementation (D&I) science spanning substance use disorder and pain intervention research and practice, and across the four pillars of the US Health & Human Services National Overdose Prevention Strategy. Organized by four synergistic, dynamic cores, the RASC is steadfast and strategically focused on assessing, supporting and enhancing the D&I capability of the HD2A Innovation Projects—nimbly and adaptively responding to intervention research studies of any type, at any stage of development, in any setting, using any research design, and regardless of the intervention provider and/or its intended recipients. The RASC meets all stipulated requirements as outlined in the RFA, but has greater ambitions: To shift the paradigm in D&I science for substance use and pain intervention research, and thereby improve equitable access to the best health care available for persons and communities living with substance use disorders and pain.